Insulin-Like Growth Factor-1 and Atherosclerosis

PROJECT SUMMARY / ABSTRACT
Coronary heart disease is a primary contributor to cardiovascular disease worldwide. Despite optimal treatment
many patients remain vulnerable to ischemic events. While small animal models have proven extraordinarily
effective at exploring mechanisms, studies in large animal models are critically needed, as a bridge between
rodent studies and human trials, and to develop new therapies. We have shown that insulin-like growth factor-1
(IGF-1) reduces atherosclerotic burden and promotes features of plaque stability in Apoe-/- mice and in Rapacz
swine with familial hypercholesterolemia (FH pigs). Our novel findings indicate that IGF-1 reduces the
number of senescent cells, including senescent SMC-like and MF-like cells in pig coronary
atherosclerotic plaques, in particular in the fibrous cap (FC). Cellular senescence is thought to play a vital
role in aging and in the development of chronic disease. However, the relation between IGF-1, cell senescence
and atherosclerotic disease is virtually unknown. Senescent cells contribute to atherogenesis and fibrous cap
thinning in mouse models, but there is no information on the causal role of cell senescence in atherogenesis in
large animal models or in humans. Using scRNA-seq analysis of aortas from Apoe-/- mice and spatial
transcriptomics analysis of porcine plaque we show high-level expression of the senescence-associated
secretory phenotype (SASP) factor IGF binding Protein-7 (IGFBP7), an IGF-1 inhibitor, in the fibrous cap,
primarily localized to SMC-like cells, particularly fibromyocytes. Elevated senescence scores are strongly
associated with fibromyocytes and high IGFBP7 expression. We hypothesize that senescent cells inhibit
IGF-1 signaling and that SASP-induced IGF-1 resistance reduces anti-atherosclerotic effects of IGF-1.
Our data shows that conditioned medium from senescent cultured SMC inhibits IGF1R signaling in SMC, an
effect reversed by anti-IGFBP7 antibody. Our overall goal is to demonstrate that removal of senescent cells
using a senolytic, ABT263, will reduce atherosclerosis in a large animal model and potentiate anti-atherosclerotic
effects of IGF-I. We will also demonstrate the role of IGFBP7 in IGF-1 resistance using a loss-of-function murine
model, and further explore mechanisms using in vitro studies.
Specific Aim 1: Test the hypothesis that clearance of senescent cells using a senolytic in a large animal
model of atherosclerosis will reduce atherosclerotic burden and potentiate IGF-1 ability to reduce
atherosclerotic burden and promote plaque stability. scRNA-seq, spatial transcriptomics, multi-marker
histology, and laser capture microdissection (LCM) will be used to dissect mechanisms.
Specific Aim 2: Specific Aim 2: Demonstrate that genetic deprivation of IGFBP7 in SMC-like cells
enhances anti-atherosclerosis effects of IGF-1. We will use SMC-selective IGFBP7-deficient mice, scRNA-
seq analysis and in vitro models to dissect mechanisms.

Public health relevance
PROJECT NARRATIVE Despite advances in prevention and treatment of cardiovascular disease, it remains the leading cause of death in the US. In many cases the underlying cause is atherosclerosis of cardiac and cerebral arteries. We will test the ability of insulin-like growth factor-1 and a novel senolytic drug, ABT263, to prevent progression and worsening of atherosclerosis in a large animal model, and also use mouse models to understand underlying mechanisms and develop new therapies for cardiovascular disease.